AMP-C: A Digital Therapeutic for Reward Dysfunction in Co-Occurring Depression and Cannabis Use

PROJECT SUMMARY / ABSTRACT
The comorbidity of cannabis use disorder (CUD) and major depressive disorder (MDD) is highly prevalent:
25% of cannabis users and 4.7% of persons with CUD meet criteria for MDD in their lifetime. Existing
treatments for CUD and MDD often target one diagnosis at a time and not both concurrently. However, prior
research indicates that integrative treatments, or those that target both disorders concurrently, yield better
outcomes for co-occurring CUD/MDD. In addition, there are accessibility issues with receiving treatment for
CUD and MDD due to time, financial, clinician availability, and stigma concerns. Digital therapeutics (DTx) may
improve accessibility, but current DTx target CUD and MDD sequentially or have frequent clinician check-ins,
limiting the impact and scalability of these DTx. Given that CUD and MDD both share deficits in reward
processing for non-drug rewards, it is likely that a DTx targeting reward processing would address this urgent
need for an integrated DTx for CUD and MDD. Dr. Collins has developed AMP-C, a DTx that targets the
reward dysfunction in co-occurring CUD and MDD. AMP-C was created using the feedback of individuals with
lived experiences of cannabis use and depressive symptoms to address the wants and needs of the users. In
the proposed K23 project, Dr. Collins will conduct a pilot randomized controlled trial for AMP-C vs an active
control group (i.e., symptom tracking) for individuals with co-occurring CUD/MDD (N = 80). The goals of the
project are to evaluate the accessibility and feasibility of AMP-C (Aim 1), the preliminary efficacy of AMP-C
compared to an active control group (Aim 2), and determine the impact of AMP-C on putative mechanisms of
change, including passive sensing data (Aim 3). Participants will be randomized to AMP-C or the active control
group, participate in the study over an 8-week period, and complete daily assessments on cannabis use, MDD
symptoms, and positive affect, as well as intensively and objectively-collected passive sensing data.
Participants will also complete assessments on cannabis use, MDD symptoms, and positive affect at baseline,
post-intervention, and the follow-up assessments at 1 month, 3 months, 6 months, and 1 year. The proposed
project is expected to yield important insight into both the understanding of the comorbidity of CUD and MDD
over time and how a DTx targeting reward dysfunction may effectively treat these co-occurring disorders. To
support her career development, Dr. Collins will work with an experienced mentorship team to receive training
in clinical trial methodology for DTx, the development and maintenance of co-occurring disorders, intensive
longitudinal methods, and mixed-methods research. The proposed project and training will provide a scalable,
integrative DTx for CUD/MDD, prepare Dr. Collins for a career as an independent patient-oriented researcher
for co-occurring disorders, and allow her to seek subsequent NIH R01 funding to further evaluate the efficacy
of AMP-C in a larger, fully-powered, randomized controlled trial.

Public health relevance
PROJECT NARRATIVE The comorbidity of cannabis use disorder (CUD) and major depressive disorder (MDD) is highly prevalent, and both disorders can be characterized by a reduced sensitivity for non-drug rewards. Few interventions have been created to target these disorders concurrently, including targeting reward dysfunction, and access to traditional in-person interventions create a barrier for receiving care. Thus, the goal of the proposed project is conduct a randomized controlled trial to evaluate the feasibility, acceptability, and efficacy of Amplification of Positivity - Cannabis Use Disorder (AMP-C), a DTx that targets reward dysfunction, compared to an active control group, in persons with co-occurring CUD/MDD.